Eosinophils as Effectors of Antibacterial Immunity in the Lungs

Pneumonia results from uncontrolled lung inflammation and injury often triggered by viral/bacterial pathogen
insults. Pneumococci, instigating agents of bacterial pneumonia, are independently pathogenic causing lower
respiratory tract infections and hospitalizations in adults, including those with chronic pulmonary conditions like
asthma. Pneumococci are also opportunistic pathogens particularly synergizing with respiratory viruses, like
influenza A virus (IAV), to cause severe morbidity and excess mortality. Our prior work established that IAV
infection during heightened eosinophilic allergic inflammation was host protective, recapitulating clinical data
from the 2009 Swine Flu pandemic. Using a laboratory model we developed to investigate mechanisms by which
this protection occurred, we identified novel functions for eosinophils as direct mediators of antiviral immunity
during early and late phases of IAV infection. Importantly, eosinophilic asthma was also host protective during
co-infection with IAV and Streptococcus pneumoniae (Spn), an outcome that was lost in eosinophil deficient
mice. Further preliminary data show that eosinophils, a) internalize Spn in large numbers, b) kill intracellular and
extracellular Spn, c) undergo physiologic and phenotypic alterations in response to Spn uptake. These data led
to our central hypothesis that eosinophils in allergic airways promote anti-bacterial immunity against Spn through
direct and indirect mechanisms to reduce the bacterial load and safeguard the host. The two overlapping aims
to be investigated in this project are: (1) To determine mechanisms and outcomes of interactions between
eosinophils and Spn, and (2) To elucidate pathways by which eosinophil-Spn interactions impact surrounding
leukocytes important in mucosal host defense during co-infection. This project is significant because we propose
to identify basic immune mechanisms in pulmonary host defense against a prominent human pathogen with an
innovative approach of investigating eosinophils as a regulator of local innate immunity and mediator of host
protection rather than as an end-stage effector cell. These studies will have a broad impact on eosinophil biology,
on our appreciation of host-pathogen interactions in allergic asthma and may offer novel therapeutic targets to
treat bacterial co-infections during influenza in allergic hosts.

Public health relevance
We propose studies to investigate the mechanisms by which eosinophils contribute to antibacterial host defenses during opportunistic pneumococcal bacterial infection. These studies are relevant to public health because they will provide mechanistic insight into immune responses in hosts with allergic asthma during synergistic viral and bacterial co-infection. Identified mechanisms may provide novel insights into unforeseen targets of intervention that may be broadly applicable.